PRG4/Lubricin glycoform variants associated with endocardial infections and sepsis

PROJECT SUMMARY/ABSTRACT
Proteoglycan 4 (PRG4, also known as lubricin) is a mucin-like protein best known for its role as an
important lubricant in joint fluid. The O-linked glycans (over 100 per PRG4 polypeptide) contribute to more than
50% of the mass, and are responsible for the lubricating and anti-adhesive properties. Aberrant glycosylation,
specifically decreased sialic acid and branched structures, is correlated with impaired rheological properties
and osteoarthritis. PRG4 is also expressed in the heart, lungs and liver, and circulates in blood. However, the
role in these other tissues is unclear. PRG4 has been reported to dampen inflammatory responses, but has
also been linked to pathologies such as aortic valve stenosis and the formation of necrotic hepatic vascular
thrombi. Very recently, it has been implicated in the acute phase response to vascular infections, and our own
studies have shown elevated plasma levels in animal models of infective endocarditis (IE). We previously used
a combination of lectin blotting and mass spectrometry to characterize the O-glycans linked to PRG4 in healthy
human plasma, as well as plasma and cardiac valve tissue from rat and rabbit models of IE. We found that the
O-glycans on PRG4 from plasma of healthy rats resembled those of healthy humans. However, in addition to
increased PRG4 levels, the O-glycan modifications were altered in IE animals (just a single type of
trisaccharide structure, rather than the assortment of ~20 different structures seen in healthy animals). We
hypothesize that distinct PRG4 glycoforms will likewise be associated with vascular infections in humans, and
that these differently glycosylated forms will have different immunomodulatory or mechanical functions. Thus,
as a prelude to mechanistic studies, we need to first clearly define the range of plasma PRG4 glycoforms
evident in human health and disease. The overall aim of this project is to develop methods for the rapid and
high through-put detection of PRG4 glycoforms in minimally processed plasma samples, and then determine
the prevalence of aberrantly glycosylated PRG4 in plasma from a cohort of sepsis patients. We will use a
cutting-edge glycoproteomics mass spectrometry approach to precisely characterize the differences between
PRG4 isolated from our banked samples of rat plasma collected pre- and post-infection. We will also use the
banked IE and healthy rat plasma, along with our unique set of streptococcus-derived sialoglycan-binding
probes, to develop a high-precision ELISA for determination of PRG4 levels and relative amounts of disease-
associated (trisaccharide-modified) glycoforms. We will then determine whether comparably different
glycoforms are evident in healthy human and sepsis patient plasma, and assess whether the PRG4 levels or
O-glycan variations correlate with sepsis phenotype, or with biological variables such as age, sex, or ethnicity.
The results will aid the design of larger mechanistic studies that address how PRG4 impacts vascular repair,
coagulopathies and inflammatory responses. Although the focus is on PRG4, the results will be applicable to
the detection and characterization of glycoform variants of mucins and mucin-like proteins in general.

Public health relevance
PROJECT NARRATIVE Proteoglycan 4 (PRG4, also known as lubricin) is a mucin-like glycoprotein that circulates in the bloodstream, but how it functions in the blood is unknown. This project aims to improve the ability to identify specific O-glycan modifications, and track changes in PRG4 O-glycosylation that occur concomitant with vascular infections. The ability to detect and purify differently-glycosylated PRG4 populations will aid the study of PRG4 functional properties, and facilitate a better understanding of the role in vascular damage and repair.